Promoting Communication Well-Being with Stutter-Affirming Therapy: A Pilot Clinical Trial in the Schools

PROJECT SUMMARY/ABSTRACT
CANDIDATE: Dr. Naomi Rodgers is an academic speech-language pathologist and Assistant Professor at the
University of Iowa with expertise in scale development, qualitative methodologies, and experimental design in
the study of the psychosocial aspects of stuttering. With this K23 mentored patient-oriented career development
award, Dr. Rodgers will build on this foundation to develop new knowledge and skills needed to independently
conduct clinical trials of multidimensional therapy for people who stutter, and to investigate factors related to
intervention implementation. CAREER DEVELOPMENT PLAN: Dr. Rodgers will develop proficiency in (1)
design and conduct of clinical trials of behavioral health interventions; (2) dissemination and implementation
science; (3) team science and multi-site project management; and (4) school-based research. Developing these
advanced skills will be critical to her success as an independent investigator who is committed to enhancing
accessibility and implementability of effective stuttering therapy that improves psychological and communicative
well-being for people who stutter across the lifespan in diverse clinical settings. ENVIRONMENT: Dr. Rodgers
will train with a multidisciplinary team of extramurally funded mentors including: Dr. Elizabeth Walker (primary
mentor), a leading applied researcher in the field of pediatric communication disorders; Dr. Geoffrey Curran (co-
mentor), a leading implementation scientist; Dr. Gerta Bardhoshi (co-mentor), a leading school mental health
researcher; and Dr. Anu Subramanian (co-mentor), a specialist in stuttering intervention and clinical education.
RESEARCH: Although many school-based speech-language pathologists (SLPs) recognize that stuttering
therapy should address cognitions and emotions alongside communication behaviors, status quo speech therapy
often narrowly focuses on reducing stuttering frequency. There is a critical lack of high-level evidence for
multidimensional approaches for school-age children who stutter (CWS), and it is unclear how to best support
school SLPs in facilitating them. Avoidance Reduction Therapy for Stuttering (ARTS®) offers a theory-driven
stutter-affirming approach to coaching CWS to reduce conditioned struggle behaviors in turn helping them
develop comfortable, forward-moving communication. Aim 1 of this study involves partnering with topical experts
and stakeholders to adapt ARTS® for school service delivery and develop a protocol to train school-based SLPs
to implement ARTS® with school-aged CWS (aged 7-12 years). Aim 2 is to conduct a pilot randomized controlled
trial with SLP-CWS dyads to evaluate preliminary effects of the ARTS® training and intervention on SLP and
CWS outcomes, respectively. Aim 3 is to identify outcomes, barriers, and facilitators of implementing ARTS® in
the schools, and to select and operationalize strategies to that we will evaluate in a subsequent fully powered
hybrid effectiveness-implementation trial. The completion of these training and research aims are critical for Dr.
Rodgers’ career development in creating, adapting, and evaluating evidence-based, implementable behavioral
health interventions for people who stutter to enhance their quality of life and well-being.

Public health relevance
PROJECT NARRATIVE Status quo stuttering intervention often narrowly focuses on increasing speech fluency which not only fails to address the totality of children’s stuttering experience, but can be detrimental to their mental health. The purpose of this research is to address this public health issue by training school speech-language pathologists to provide stutter-affirming intervention to school-aged children, piloting its effectiveness on children’s communication well- being, and identifying outcomes, determinants, and strategies related to its implementation. This proposal addresses priorities set forth by NIDCD to (a) translate and implement scientific advances into standard clinical care, as the school context is where most children who stutter receive speech therapy services, and (b) for communication disorders researchers to pursue research and training in dissemination and implementation science.